Leveraging the Uniquely High Beta-Cell Zinc Content for Targeted Drug Delivery

PROJECT SUMMARY
Diabetes is a disorder of glucose homeostasis that causes excess hospitalization, morbidity and early mortality
among the more than 34.2 million disease-affected Americans. Consequently, developing pharmacologic
methods to preserve β-cell function and/or stimulate β-cell mass expansion is of intense interest. Presently, the
creation of improved diabetes medications is stymied by a dearth of safe therapeutic targets. In fact, on-target
but off-tissue drug effects are slowing progress across multiple diabetes therapeutic domains including β-cell
regeneration, β-cell preservation, and immune-protection. In principle, stimulating the regeneration of insulin-
producing β-cells could be used to restore or enhance endogenous insulin production capacity. Recently, we
developed several new highly potent chemical inducers of human β-cell proliferation. However, the non-selective
growth-promoting activity of these molecules prevents further clinical development. Consequently, a “modular”
(readily transferable) system for β-cell-targeted drug delivery is needed to realize the next generation of diabetes
therapeutics. To address this challenge, we are developing a β-cell-targeted drug delivery module based upon
the uniquely high zinc content of β-cells. In this system, a zinc-chelating moiety is covalently integrated into a
replication-promoting (cargo) compound to generate a bi-functional compound (βRepZnC) that selectively
enhances β-cell drug accumulation and replication-promoting activity. Here, we combine a medicinal chemistry
effort with systematic in vitro and in vivo interrogation to advance our platform technology for β-cell-targeted drug
delivery. In Aim 1, we will define the chemical “rules” that govern zinc-dependent β-cell targeting. We will
synthesize and assay diverse βRepZnCs where cargo/chelator composition, zinc-binding affinity and
physicochemical properties are systematically varied. In Aim 2, we will examine the in vivo β-cell selectivity
(accumulation and replication-promoting activity) of systemically-delivered βRepZnCs. We will use desorption
electrospray ionization mass spectrometry (DESI-MSI) to measure tissue-specific drug accumulation and predict
tissue-specific bioactivity. This work will demonstrate the in vivo efficacy of novel βRepZnC therapeutics in
multiple diabetes mouse models and deliver a validated methodology; overcoming a major barrier to developing
cell-targeted therapeutics: the lack of a facile method for in vivo measurement of tissue-specific drug delivery.
In Aim 3, we will use CRISPR technology to genetically dissect the pathways that control β-cell zinc and zinc-
binding drug accumulation. As part of this effort, we will genetically enhance β-cell βRepZnCs accumulation and
β-cell selective replication induction. Overall, our studies will advance a modular technology for β-cell-targeted
drug delivery, optimize βRepZnCs, validate a greatly needed tool for assessing cell-targeted drug delivery in vivo
and provide fundamental (targetable) insights into β-cell biology.

Public health relevance
PROJECT NARRATIVE β-Cell dysfunction and depletion are pathologic features of diabetes. A regenerative therapeutic strategy for diabetes, while promising in principle, is contingent upon successful development a method for selectively targeting replication-promoting compounds to the β-cell. The extraordinary power of medicinal chemistry and a rigorous experimental interrogation cascade will be leveraged to deliver a β-cell-selective regenerative compound and define the chemical/genetic “rules” that govern β-cell selective drug delivery based upon their unique biologic properties.